Administrative Core

ABSTRACT- ADMINISTRATIVE CORE The Administrative Core will coordinate the scientific and administrative activities of this Duke Center for Structural Biology, ensuring that the Projects and Cores function well together. In particular, it will be responsible for managing the program’s financial management, program management, and coordinating Projects and Cores through scientific meetings and communications, as well as ensuring full financial and regulatory compliance. A primary activity of the Core will be monitoring Center progress relative to milestones and measuring this progress against available funding to ensure resources are used efficiently. As Specific Aims, the Core will provide overall Center management, coordination and supervision of the Program (Aim 1), ensure timely financial accounting and reporting (Aim 2), ensure compliance with all institutional, state, and federal research guidelines (Aim 3), develop and implement Center communication, publication, and data sharing plans, including website development and outreach communications to non-Center structural biologists (Aim 4), and provide statistical support for all data analyses (Aim 5). The Core will coordinate an annual meeting with a Scientific Advisory Board (SAB) that will review the progress of Center Projects and Cores, and with input from the DAIDS Program Team, provide guidance for the Program’s direction. Core staff are part of a highly experienced and integrated management team, which will enable immediate start-up and rapid progress. This teamwork will accelerate advancement toward the Center’s goals, thus maximizing the opportunities to positively impact HIV-1 vaccine and cure research.